Project 1: Decoding, Modeling and Targeting Oncohistones and an Oncohistone-like Protein

PROJECT SUMMARY
We were one of two groups to first identify amino acid substitutions on histone H3 variants (oncohistones) in
human disease. In the past funding cycle, we showed that, beyond their initial identification in specific subtypes
of high-grade gliomas and bone tumors, these oncohistones also occur in subgroups of sarcomas, head and
neck squamous cell carcinomas, and acute myeloid leukemias. Working with members of this Program Project,
we showed how H3K27M and H3K36M (K-to-M substitutions) lead to stalled development and blocked
differentiation through epigenome rewiring as they promote aberrant spreading/redistribution of key chromatin
marks from their initial boundaries, which in turn facilitate oncogenesis. Furthermore, our collaboration with
Lewis/Garcia labs uncovered that, EZHIP, a testis-specific protein aberrantly expressed in posterior fossa group
A ependymomas, biochemically mirrors H3K27M oncohistone. Our preliminary data indicate that EZHIP is also
aberrantly activated in subgroups of osteosarcomas. In contrast to the growing information on K-to-M mutations,
however, there is limited knowledge on the oncogenic function, molecular mechanisms and tumor-specific
vulnerabilities of the oncohistone-mimic EZHIP and mutations affect H3.3G34. In large part, this is due to a
paucity of resources and models that faithfully recapitulate the cellular effects mediated by these alterations.
Therefore, a major goal of this project is to develop and employ novel patient sample-, cell culture- and animal
model-based systems to model oncohistone-associated cancers and investigate the underlying pathogenic
mechanisms. Nearly all G34 mutations affect histone variant H3.3, and while H3.3G34R/V are frequently found
in pediatric gliomas, giant cell tumors are predominantly defined by H3.3G34W mutations. This dichotomy is
reflected by the distinct phenotypes of the H3f3a G34W, R or V knock-in mouse models we have developed. We
aim to delineate the mechanisms behind the codon-specific phenotypes resulting from H3.3G34 mutations, the
role of specific mutational partnership for G34R/V-driven tumorigenesis, and the necessity of H3.3 variant in
mediating G34-dependent phenotypes (Aim 1). We will investigate the role of EZHIP in development, how its
aberrant expression is achieved and promotes oncogenesis in osteosarcomas and ependymomas - comparing
and contrasting to H3K27M mutation (Aim 2). Lastly, we will build on our findings of the viral mimicry induced by
K-to-M mutations to assess the degree and nature of immune infiltration in these tumors at baseline and upon
treatment of epigenetic drugs (Aim 3). Notably, these studies are enabled by the unique syngeneic mouse
models and CRISPR/Cas9-edited isogenic patient-derived tumor cell lines we have generated for various
oncohistones and EZHIP. This project will synergize with other efforts of this Program Project to provide
mechanistic insights and relevant and reliable pre-clinical models to the community, building a knowledge and
resource base upon which targets amenable to therapy that can be conceived and validated.

Public health relevance
PROJECT NARRATIVE Discovery of mutations in histone genes (oncohistones) in deadly cancers has uncovered a novel mechanism of oncogenesis with deregulation of normal development at its core. We aim in this project to understand how the H3.3G34 mutations and the new oncohistone-mimic EZHIP act to promote oncogenesis, identify targets amenable to therapy, provide relevant pre-clinical models, and design strategies to optimally engage the immune system to improve survival and provide cure for patients with oncohistone-associated cancers.